CTSA K12 Program at Stanford

Training the next generation of translational scholars who can innovate, think creatively, and
apply rigorous and responsible research principles to major problems is society's best chance to
recoup its enormous investment in biomedical research. The Stanford CTSA's Mentored
Research Career Development Program (K12) sits at the center of a dynamic Stanford and
Silicon Valley ecosystem of biomedical research at all stages, from basic discovery to practical
implementation. Our KL2 program has a 15-year history of successfully training Scholars to
become exceptional scientists, leaders, and mentors. Our Scholars have over 2,749
publications (average 58 each) cited over 45,000 times since graduation, and all who have
graduated since 2021 in the last two cycles have received subsequent independent research
funding. That success has rested on a philosophy of practical, individualized training tailored to
the Scholars and focused on the established characteristics of successful translational
scientists. We will provide tailored mentoring and career development to four instructors and
junior faculty from varied disciplinary backgrounds each year. Our alliance with the VA early
career and Center for Digital Health training programs brings new colleagues into our scholarly
community. Thematic emphases include leveraging developments in informatics to accelerate
translational research, interdisciplinary teams, and enhancing the rigor and reproducibility of
clinical research to ensure that translated products will truly benefit patients. The science of
translation brings that rigor to the study of moving research across the translational spectrum
and is embedded throughout our program. We have a strong recruitment plan and rigorous
evaluation process to ensure that we attract the best Scholars. We structure our program
around four specific aims: mentorship, education and professional development, evaluation, and impact. We have assembled a world-class faculty committed to training and mentoring our
Scholars who together have a research program funded in excess of $350 million. The MPIs are
both award-winning mentors with strong experience in leading large research projects and
synergistic strengths. We have also assembled an outstanding team of mentors specific to
community engagement and analytic methods, as well as a strong emphasis on peer mentoring.
The education and professional development aim covers not just the domains of translational
research and the science of translation, but lectures and experiences designed to imbue
Scholars with the practical and leadership skills they will need to succeed. Our talented External
Advisory Board of nationally renowned educators and scientists will, together with the
Community Advisory Board, give the program strategic guidance. A robust evaluation and a
long-term outcomes tracking plan ensures that we will continuously improve this program and
maximize impact.

Public health relevance
Stanford CTSA’s Mentored Research Career Development Program (K12) will train the next generation of translational Scholars in biomedical research. The program emphasizes practical, individualized training tailored to the Scholars and focuses on community engagement, informatics, and rigor and reproducibility, and the new science of translation to ensure translated products truly benefit patients. Our accomplished faculty are committed to mentoring Scholars across disciplines and translational stages and building on a 15-year history of scholars who have gone on to independent research funding and leadership role